CEREBRAL BLOOD FLOW AND METABOLISM IN NORMALS TREATED ORALLY WITH FLEROXACIN

To determine the cerebral blood flow, glucose and/or oxygen metabolism are effected by a three day course of fleroxacin or placebo administration. This was a question because of the CNS adverse effect profile of this group of antibiotics.